Safer Metal Based Imaging Agents

Project Summary
Metals offer a stunning array of properties that can be exploited for biomedical purposes. Metals such as
platinum, ruthenium and copper are used in chemotherapy. Yttrium and indium are used in radiotherapy.
Neodymium, europium and terbium are finding application in luminescent probes. Copper, gallium and whole
host of other metal isotopes can be used in PET and SPECT imaging. Gadolinium is widely used in MRI, while
manganese is proposed as an alternative. However, these advantageous properties come with a price: the risk
of metal ion toxicity.
To make metals safe for most in vivo application they must be held tightly in a coordinating ligand. The purpose
of this ligand is to shield the body from the metal ion, avoiding the body’s natural metal transport and storage
systems and permit the metallo-pharmaceutical to perform as intended. But most crucially this ligand allows the
metal ion to be excreted.
Broadly speaking, metals fall into one of two categories: 1) Those to which evolving life was exposed and took
advantage: the essential minerals. And 2) those to which evolving life had no exposure and are not normally
found in lifeforms: the xenobiotic metals (which includes many of the heavy metals). One might expect that these
two classes of metal ion would be fundamentally different, but, they share a common feature in biology: neither
can be excreted. Xenobiotic metals because these pathways never developed and essential minerals because
they are too valuable to lose.
Clearly metal ions escaping from the ligands in which they are administered represents a serious problem and
risk to human health. Once out of the ligand they are incorporated into the body and can never leave. This
means that the complexes formed between metal and ligand must be as robust as possible. Although there are
some excellent ligand systems already in use in clinical medicine, concern continues to exist about the release
of metal ions from these ligand structures. The aim of this small project is to investigate whether a small, and
comparatively simple, modification to these ligand systems would lead to substantial improvements in the
robustness of the complex. If so it will have the effect of paving the way to yet safer ligand systems for metals
in biomedical applications.

Public health relevance
Project Narrative Metal chelates have become invaluable components of many diagnostic imaging agents, but the major risk factor associated with the use of these agents remains the potential release of metal ions into the body. Several high- profile instances, such as the recent concern about gadolinium deposition, serve to highlight the problem that metal ion release can pose in the use of imaging agents. The aim of this small project is to establish whether a simple substitution strategy can be employed to develop more robust chelates, minimizing metal ion release.